The Impact of Beta- and Gamma-synucleins on Alpha-synuclein's Synaptic Function

PROJECT SUMMARY/ABSTRACT
αSynuclein (αSyn) plays an important role at the synapse, to maintain neurotransmitter release via clustering
synaptic vesicles (SV) and chaperoning SNARE-complex assembly. Aggregation of αSyn is a key pathological
feature in multiple age-driven neurodegenerative diseases such as Parkinson’s disease (PD) and Alzheimer’s
disease related dementias (ADRD) such as Lewy body dementia. Despite the involvement of βSyn and γSyn in
synucleinopathies including Lewy body dementia, Gaucher’s disease, and PD, virtually nothing is known about
their physiological functions in the brain. Understanding their function is the first step to finding out how their
dysfunction causes PD and Alzheimer’s disease related dementias including Lewy body dementia, and how
these diseases can be prevented or delayed. The objective here is to determine the effects of βSyn and γSyn
on αSyn’s synaptic function. The central hypothesis is that interaction of βSyn and γSyn with αSyn causes a
reduction in αSyn’s activity, leading to reduced SV clusters and SNARE-complex assembly, and altered neu-
ronal activity. This hypothesis will be tested in 3 specific aims: 1) Assess the effect of βSyn and γSyn on
SNARE-complex assembly; 2) Assess the effect of βSyn and γSyn on SV clustering; and 3) Determine the im-
plications of synuclein interactions on SV cycling. Under aim 1, SNARE-complex assembly will be quantified in
select brain areas and neurons from mice lacking βSyn and/or γSyn, in heterologous cells and using recombi-
nant proteins. Under aim 2, synaptobrevin-2 binding and multimerization of αSyn, and SV pools will be quanti-
fied in mice lacking βSyn and/or γSyn and using recombinant proteins. Under aim 3, SV exocytosis and cycling
will be quantified in hippocampal brain slices and in neurons from mice lacking βSyn and/or γSyn with or with-
out lentivirally increasing βSyn or γSyn levels. This research is innovative because it (1) tests the novel hypoth-
esis that βSyn and γSyn affect the synaptic function of αSyn, (2) uses a multidisciplinary approach combining
biophysical, biochemical, electrophysiological and whole animal approaches, and (3) analyzes new mouse
models lacking βSyn and/or γSyn that were generated from αβγSyn triple knockout mice, that not only enable
a direct comparison of the synucleins but may serve as models for synucleinopathies and Alzheimer’s disease
related dementias including Lewy body dementia. Our work is significant because it (1) will clarify the im-
portance of βSyn and γSyn for neuronal function, (2) will provide new insights into the molecular mechanism
underlying SV binding of αSyn, (3) may uncover the contributions of βSyn and γSyn to synucleinopathies and
Alzheimer’s disease related dementias including Lewy body dementia, and (4) has translational importance for
the targeted development of new treatment strategies for the above-mentioned age-driven dementias aimed at
targeting all synucleins instead of focusing solely on αSyn. With synuclein pathology and co-pathologies com-
mon to PD and Alzheimer’s disease related dementias including Lewy body dementia, our study has the poten-
tial to contribute a mechanistic understanding of the role of the three synucleins in these synucleinopathies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because alpha-, beta-, and gamma-synuclein pathology is linked to neurological diseases including Parkinson’s disease, Lewy body dementia, Amyotrophic Lateral Sclerosis, and understanding the physiological roles synucleins play in the brain will allow us to better understand the underlying disease mechanisms and develop novel intervention therapies. Thus, this research is relevant to the NIH’s mission that pertains to supporting the ongoing basic research, foster research that has immediate medical relevance, and encourage translational research that links the discoveries from basic research into therapeutic interventions for treating neurological disorders such as Parkinson’s disease and Lewy body dementia.